Defining T cell-placenta immune mechanisms in chronic villitis

PROJECT SUMMARY
Chronic villitis of unknown etiology (CVUE) is diagnosed in 10-15% of all term placentas and is characterized
by the infiltration of maternal T lymphocytes into the chorionic villi with corresponding trophoblast necrosis.
This inflammation accompanies 40-60% of fetal growth restriction (FGR) cases, 20-30% of stillbirths, and
infants with a CVUE diagnosis are 4 times more likely to be neurodevelopmentally delayed. Importantly,
approximately 55% of patients with a CVUE diagnosis will have recurrent disease, making this a clinically
significant placental finding. However, consequences of this diagnosis are rarely considered clinically due to
the paucity of data surrounding the biologic mechanisms promoting CVUE. These gaps have resulted in our
inability to predict and/or prevent new and recurrent disease. CVUE is hypothesized to be either a maternal
alloimmune response to the fetus or an undiagnosed infection, both of which would have shared
immune mechanisms but different antigen targets. We previously showed that CVUE placenta
downregulate immune checkpoint receptors and upregulate major histocompatibility complex (MHC) to
promote T cell activation. We also demonstrated that expansion of T cell clones occurs during CVUE, but not
in response to common viruses. Preliminary data presented in this application demonstrates that patients with
CVUE have elevated proinflammatory cytokines and chemokines in the blood and placenta and these maternal
T cells may be responding to a common placental antigen. Still, there remains no definitive explanation as to
the antigen specificity or local mechanisms at the maternal fetal interface that control or amplify this abnormal
immune response. Therefore, this study is significant as it will define whether CVUE is an infectious or
alloimmune pathology and describe changes in placental MHC and co-stimulatory receptor expression which
leads to activation and cytotoxicity by maternal T cells against these antigens. Access to unique institutional
resources, multidisciplinary expertise, and novel approaches makes our application highly innovative. Our
hypothesis is that increased major histocompatibility complex (MHC) expression on antigen presenting cells
(APCs) in the periphery and trophoblast cells of the placenta promotes maternal T cells to recognize and
respond to fetal antigens, leading to CVUE. We will address this hypothesis in two specific aims by: 1)
assessing the impact of CVUE inflammation on MHC and co-stimulatory receptors in the placenta to promote T
cell mediated cytotoxicity and 2) identifying mechanisms of maternal T cell activation and expansion in
response to fetal-specific antigens during CVUE. This study will create the most comprehensive immunologic
understanding of systemic- and tissue-mediated mechanisms of CVUE pathogenesis to date. These data are
critical for future studies that address diagnosis of CVUE in utero and test therapeutic strategies, such as
immune modulating agents, for prevention of CVUE and its associated fetal morbidity and mortality.

Public health relevance
PROJECT NARRATIVE Inflammation in the placenta can cause harm to the developing baby and to future pregnancies; yet, often there is no explanation as to why it occurred. Our goal is to uncover the interactions between the mother’s immune system and the fetal placenta that are altered, resulting in a chronic villitis of unknown etiology diagnosis at birth. Understanding these interactions can lead to new ways to diagnose and treat this damaging inflammation, leading to improved pregnancy and infant outcomes.